REGIONAL CEREBRAL METABOLIC ACTIVITY DURING REM SLEEP IN MOOD DISORDER

This study is designed to determine if the measurement of regional cerebral metabolic rate of glucose during REM sleep (rCMRgluREM) will provide a more sensitive measure of limbic dysfunction in depressed patients than will waking rCMRglu.